Point of Care HIV-1 Diagnosis to Improve Rates of ART Initiation among Infants

Abstract Pediatric AIDS remains a public health emergency in Zambia, with the majority of new infections resulting from perinatal transmission. Early infant diagnosis (EID), timely initiation of antiretroviral therapy (ART), and effective long-term clinical follow-up are critical to programmatic success and to saving the lives of HIV-infected children. In Zambia, the current standard for diagnosis of infant infection is HIV DNA PCR, performed at one of only three reference laboratories in the country. High clinical volume and long specimen transport times can result in diagnostic delays of many weeks, and this is believed to contribute to substantial program attrition and poor clinical outcomes. We propose a randomized, controlled trial of a new point-of-care (POC) technology for early infant HIV diagnosis, developed at the University of Cambridge, U.K. We will introduce the Simple AMplification-Based Assay (SAMBA) in 2 postnatal facilities in Lusaka, Zambia, where the standard of care is to offer off-site DNA PCR to all HIV-exposed children at 6 weeks of life. Eligible, HIV-exposed infants will be randomly assigned to SAMBA same-day infant diagnosis or the current standard of care. Our primary outcome will be the proportion of HIV-infected children in each study arm who commence antiretroviral therapy within 12 weeks of the diagnostic specimen being drawn. Our secondary outcomes will include: 1) a comparison of time to ART initiation in each study arm, 2) the proportion of HIV-exposed children who remain in care at 6 months of life (stratified by HIV status), and 3) feasibility of the SAMBA technology in our setting. 2

Public health relevance
Project Narrative Timely diagnosis, early initiation of antiretroviral treatment, and effective long-term clinical follow-up can prevent serious morbidity and mortality among HIV-infected newborns. In this application, we propose a randomized, controlled trial to determine whether offering a novel point-of-care early infant HIV diagnostic test with same-day results (known as SAMBA) will result in a higher proportion of HIV-infected infants initiating antiretroviral treatment within 12 weeks of diagnosis, compared to the current standard of off-site HIV DNA PCR testing. 3 __SpecificAimsTextDelimiter__ Specific Aims Specific aim #1: To determine whether offering point-of-care early infant diagnosis (EID) with same-day results at 6 weeks of life will result in a higher proportion of infants initiating antiretroviral therapy (ART) within 12 weeks of HIV diagnosis (the date on which the specimen is drawn), compared to the current standard of off-site DNA PCR testing with results at a subsequent visit. Specific aim #2: To determine whether offering point-of-care EID with same-day results at 6 weeks of life reduces the interval between HIV diagnosis (the date on which the specimen is drawn) and ART initiation among HIV-infected children. Specific aim #3: To determine whether offering point-of-care EID with same-day results at 6 weeks of life improves retention in care at 6 months among two populations of HIV-exposed children: (a) Those found to be HIV-infected, (b) Those found to be uninfected. 4